The Chromium Connect, an integrated and robotic system to automate library preparation for single-cell RNA-Seq

PROJECT SUMMARY/ABSTRACT We are proposing the acquisition of a Chromium Connect System. The proposed instrument will be placed in a shared setting at the Stanford Center for Genomics and Personalized Medicine (SCGPM) Sequencing Service Center and operated by a highly trained group of staff experienced in genomic technologies. The SCGPM Sequencing Service Center is a core facility that was founded in 2009 and is open to the entire Stanford community. Since its inception the SCGPM Sequencing Service Center has produced sequencing data for over 700 Stanford researchers and more than 150 laboratory groups. Single cell sequencing has become a transformative tool in the biomedical research space and the rapid decline in the cost of sequencing has generated a need for consistent and reliable high-throughput library preparation. The presence of a Chromium Connect will greatly increase the library preparation capabilities of the center as well as shorten turnaround times for preparing libraries. The Major and Minor Users highlighted in this proposal range from junior faculty who are just starting their own laboratories to established full professors with over 30 years of research experience. Nearly all of the users have NIH funding, and their genomic studies depend on affordable and customizable ultra high-throughput, next generation sequencing technologies. We predict that use of the Chromium Connect System will approach maximum capacity due to the high demand and need for cost-effective library preparation. Data generated by sequencing libraries prepared with the proposed instrument will positively impact a broad cross section of human disease research, notably: cardiovascular disease, pulmonary hypertension, type 2 diabetes mellitus, inflammatory bowel diseases, developmental defects, cancer, sleep disorders, obesity, and aging. The research performed in these studies will help pave the way for better interpretations of the human genome as well as the translation of new assays and technologies to the clinic. Stanford researchers who perform single cell sequencing assays made possible by library preparation performed on this instrument consistently publish high profile studies, indicating the major impact that this new technology will have on biomedical research.

Public health relevance
PROJECT NARRATIVE Single cell sequencing is having a huge impact on biomedical research, allowing researchers to identify and study mechanisms of disease at a resolution and scale previously not possible. As sample library preparation is a critical step in the sequencing workflow, the purchase of the new Chromium Connect System for automated library preparation will be essential to generating consistent and reliable sequencing data. As such, it will have an enormous impact on the scientific community, enabling continuing advances in biomedical research.